MOVE: MOtiVational Strategies To Empower African Americans To Improve Dialysis Adherence

Dr. Ebele Umeukeje is a Nephrologist and a Health Services Researcher at Vanderbilt University Medical
Center. Her long-term career goal is to become a successful independent physician scientist with expertise in
kidney disease disparities research focused on improving clinical outcomes in vulnerable kidney disease
patients. In addition to demonstrating growth toward independence as a physician scientist, her short-term
career goals with support from this R03 include : 1) To gain advanced skills in the development and
implementation of novel culturally sensitive motivational strategies, and 2) To acquire critical preliminary data
for an R01-funded phase II efficacy trial testing the use of these motivational strategies to improve dialysis
treatment adherence. She is specifically interested in reducing the excessive re-hospitalizations in end-stage
kidney disease (ESKD) by intervening upon dialysis treatment non-adherence. Excessive re-hospitalizations in
ESKD has significant

Public health relevance
Excessive hospitalizations in ESKD has significant public health relevance to patients, providers and health systems due to its associated financial burden and impact on patients' morbidity and mortality and emerging evidence shows dialysis treatment adherence is an important modifiable contributor. Compared to Whites, African American ESKD patients have a four-fold higher ESKD prevalence, persistently higher hospitalization and rehospitalization risk, and higher rates of dialysis treatment non-adherence. The goals of this proposal are to 1) advance my patient-oriented clinical research skill-set and experience; 2) acquire additional preliminary data for an R01-funded phase II Efficacy trial testing the efficacy of culturally sensitive interventions to improve dialysis treatment adherence; and 3) facilitate growth toward independence as a Physician Scientist with expertise in improving adherence, reducing disparities and optimizing outcomes in ESKD.